DNA REPAIR AND AGING

The focus of this study is to examine if age-dependent alterations exist in the abilities of human cells to repair DNA damage. The emphasis of these studies will be to examine isolated cell populations that are functionally important to aging.